Balancing Act: Impact on Falls in Older Adults with Vision Impairment

DESCRIPTION (provided by applicant): Falls are a significant issue for older adults with vision impairment. Medical conditions such as glaucoma and age-related macular degeneration that result in vision impairment negatively impact balance. Falling is 1.7 times more likely among older adults with vision impairment. In 2010 there were 9,146,026 older adults treated in emergency rooms for unintentional falls and injuries from falls are expected to cost the nation an estimated $54.9 billion dollars by 2020. Falls can lead to death, depression, and loss of independence. However, impaired balance is a modifiable risk factor for falls. A practical yet innovative falls prevention program has been developed that is designed to enhance balance and proprioception among older adults. This program, U- ExCEL Balancing Act, consists of simple exercises that can be done at home (15 minutes duration-3 times a week) during normal daily activities, requires only one brief training session, and no equipment. This study aims to establish an evidence base documenting the positive impact of Balancing Act exercises on balance and fall prevention for older adults with vision impairment. A randomized controlled trial of older adults with vision impairment (best corrected vision of 20/70 or worse) will be conducted over a 6-month period (control group n = 35 and Balancing Act intervention group n = 35) to determine the impact of Balancing Act on falls, fear of falling, pain, and activity levels. Factors that can be expected to affect its adoption and sustained use such as cost in the community and social support networks in the home will also be investigated. It is hypothesized that the Balancing Act intervention will decrease the number of falls experienced by older adults who have vision impairment by improving their gait and balance, reducing their fear of falling, increasing their physical activity, and reducing their pain. The specific aims of the research are to: 1) Evaluate the impact of Balancing Act on standing balance control and proprioception for older adults who have vision impairment, using the Tinetti Gait & Balance Test, a validated tool for evaluating gait and balance and predicting fall risk; 2) Evaluate the impact of Balancing Act for older adults with vision impairment on falls, fear of falling, physical activity, and pain; and3) Improve adherence to the Balancing Act exercise program by facilitating social networks. Data will be analyzed through: 1) a descriptive assessment of the baseline demographic characteristics of sample members, covariates, and outcome variables, as well as 2) a repeated measures design examining the impact of the intervention on study participants.

Public health relevance
PUBLIC HEALTH RELEVANCE: Falls can lead to serious injury, death, and loss of independence among older adults, especially those with vision impairment. As the baby boomer generation ages and the number of cases of vision impairment from eye diseases increases, falls prevention programs that are easy for the older adult public to participate in and can result in reduced falls will become increasingly important. The proposed research will test the effectiveness of one such falls prevention program that aims to improve balance and reduce falls and can be used by older adults with vision impairment in rural areas, in their homes, and which is easily adopted by community agencies serving older adults with and without vision impairment. __SpecificAimsTextDelimiter__ Specific Aims Falls are a significant issue for older adults and especially for those who have vision impairment. Among the 65 and older population, 30% to 40% experience a fall each year and those with loss of visual acuity are 1.7 times more likely to experience a fall. Furthermore, older adults with visual impairments are 1.9 times more likely experience multiple falls when compared to their counterparts who do not have visual impairments. This population also has a 1.3-1.9 times greater likelihood of experiencing a hip fracture as a result of a fall.i In 2010, the National Center for Injury Prevention at the CDC reported that 9,146,026 people were treated in emergency rooms for unintentional falls, with individuals 75 years and older experiencing the highest rate of falls. Medical conditions such as glaucoma and age-related macular degeneration that result in vision impairments can negatively impact postural stability. Injuries sustained from falls by older adults can hamper independent living and result in an increase in the risk of premature institutionalization and death. There are significant monetary costs associated with falls as well. By 2020, injuries that result from falls will cost the nation an estimated $54.9 billion dollars.ii However, nearly 10% of falls in older adults can be prevented.iii Impaired balance is one modifiable risk factor for falls. Reducing falls among older adults who have vision impairment will be crucial with the aging of 78 million baby boomers (turning 65 years of age at the rate of 10,000 a day since January, 2011) and the doubling of age-related eye diseases over the next 30 years. A practical yet innovative falls prevention program has been developed that is designed to enhance balance and proprioception among older adults. This program, U-ExCEL Balancing Act (BA), designed by the Department of Geriatric Medicine at the University of New England College of Osteopathic Medicine, consists of simple exercises that can be performed at home (15 minutes duration-3 times a week) and requires only a single brief training session and no equipment. The acceptability, feasibility and short-term impact of this program on balance have been established in a small pre-post pilot study in which forty-four percent of the study participants showed an average improvement of 5.8% in Tinetti scores over the course of eight weeks. No adverse effects were reported during the study period. This project will adapt the BA program to accommodate older adults who have vision impairment (best corrected vision of 20/70 or worse, which is the beginning of low vision) and establish an evidence base for the impact of BA exercises on balance and falls prevention for independent-living older adults who have vision impairment. This study will explore the impact of BA on falls, fear of falling, pain, and activity levels, and will identify factors that can be expected to affect its acceptability and sustainability in the community. In addition, it will examine its potential for adoption by Maine Area Agencies on Aging as an evidence-based intervention for falls prevention. It is hypothesized that the BA intervention will decrease the number of falls experienced by older adults who have vision impairment by improving their gait and balance. The specific aims are to: 1) Evaluate the impact of BA on standing balance control and proprioception for older adults who have vision impairment, using the Tinetti Gait & Balance Test, a validated tool for evaluating gait and balance and predicting fall risk; 2) Evaluate the impact of BA for older adults with vision impairment on falls, fear of falling, physical activity, and pain; and 3) Improve adherence to BA by facilitating social networks. Falls prevention is a pressing public health goal of increasing importance as our population ages and the number of older adults with vision impairments rises (cases of age related macular degeneration are estimated to increase from 9.1 million to 17.8 million by 2050 and diabetic retinopathy cases are expected to increase from 2.5 to 9.9 million).ivThe proposed study will begin to establish the efficacy and effectiveness of an innovative balance training program on a particularly vulnerable subgroup of older adults to accidental falls - those who have vision impairment - by assessing its impact on balance and proprioception, falls, fear of falling, physical activity, and pain levels. In addition, the home-based model eliminates common barriers that rural residents face in accessing services as a result of lack of transportation. Maine, recently designated as the most rural state in the nationv, is an ideal place to test this intervention. Clinical practice with older adults will be improved by community agency utilization of a user friendly, home-based, falls prevention program meant to maximize consumer accessibility generally, and accessibility by individuals with vision impairment in particular.